Bilateral Prefrontal and Insular TMS for Depression in Schizophrenia

Project summary: Depression is a common symptom domain in people with schizophrenia spectrum
disorders. Depression in schizophrenia can be difficult to treat, leading to further functional impairment,
suffering, and even higher safety concerns in many patients. TMS to the dorsolateral prefrontal cortex is
commonly used to treat depression in general, although evidence of its efficacy for depression in patients with
schizophrenia is unclear, and indirect evidence may not support the efficacy, likely due to the more complex
underlying brain circuitry mechanism associated with the comorbid depression and schizophrenia condition.
The proposed study is to use an alternative approach to stimulate bilateral insula and lateral prefrontal cortex
that is based on a strong neural network mechanism of depression in schizophrenia. The project will recruit
patients with schizophrenia spectrum disorders and randomize them into active rTMS versus sham rTMS
groups followed by three fMRI based target engagement outcome assessments at baseline and after 10, and
20 visits of daily rTMS. The proposal will use more intense theta burst stimulation, new and diffused stimulation
sites and more stimulation sessions that are conceptualized to be more strongly modulating the neural circuitry
mechanisms linked to this sometimes devastating comorbidity. The proposal will include two phases as two
separate projects. The first proposed project is a R61 for two years. If the Go/Nogo milestones are not met, the
study will end. If all Go/Nogo milestones are met, it will proceed to a R33 project for three more years. The trial
will test the proposed mechanism of action at brain network level and determine whether the new stimulation
strategy will indeed significantly engage the proposed network through modulating its functional connectivity in
the direction for improving depression in people suffered from schizophrenia spectrum disorders.

Public health relevance
Project Narrative This project aims to develop a new way to use TMS to treat depressive symptoms in patients with schizophrenia spectrum disorders. The approach is expected to permit more targeted treatment development based on the brain mechanism linked to depression in schizophrenia, eventually leading to more effective treatment for this severe comorbid condition.